Creating a Food Safety Culture: Using the Retail Program Standards as a Guide to Improving Infrastructure and Effectiveness at the Local Level

Project Summary/Abstract HARPS Program The Harrisburg Health Office application request for funding is designed to provide personnel support, technical support and equipment to assist in the development of a comprehensive, effective and responsive food safety program. Additional personnel, enhanced technical abilities, training and updated equipment, will provide the opportunity for successful program development and implementation. The Health Office is working to enhance existing food safety programs, establish new programs and to develop new partnerships with local and regional stakeholders. The Harrisburg Health Office self-assessment has identified areas of success as well as areas of improvement to be addressed. The Harrisburg Health Office welcomes the FDA commitment to support a nationally integrated food safety system through enhancement of state, local and territorial retail food regulatory programs. The primary goals of funding will be to enhance education, increase efficiency, and eliminate the risk of food-borne illness in the retail environment. Additional outcomes include establishing partnerships with owners and community groups to increase food safety awareness and support standardized compliance efforts.

Public health relevance
Project Narritive RFA-FD-20-012 HARPS Program (Harrisburg Advancing Retail Program Standards) The City of Harrisburg, PA is requesting funding to enhance and strengthen food safety programs, address gaps identified via the self-assessment process and provide much-needed technical, training and staffing support. Identified outcomes related to the grant request include: • Create an enhanced local regulatory environment for retail food operations • Create new programs and food safety objectives related to food safety in a post-COVID-19 retail food environment • Increase capacity to manage increased demand for food safety inspections as well as address novel food establishments seeking City of Harrisburg Health Office approval • Increase operational capacity to implement strategic partnerships with local entities who share compliance responsibilities with the City of Harrisburg Health Office • Create and improve technology advancements to widely encourage uniform and complete adoption of the FDA Food Code • Increase the number of trained staff—proficient in standardization and risk-based inspection processes • Provide education allowing the adoption of food protection managers common in retail establishments. • Establishment of a long-term implementation and intervention program to consistently reduce the risk of foodborne illness The Harrisburg health office staff will use Standardized risk-based inspection protocols. The office will also be trained in the usage of the “tools of the trade”, items necessary for successful risk-based inspections, recall management, and retail closures. The Harrisburg health office will also use technology to collect data, document inspections, monitor enforcement and increase overall process efficiency. The office will also combine compatible software programs with other utilities responsible for safety compliance in retail. The Harrisburg Health Office will be a positive resource, assisting the expanding retail food service community. Programs offering training relevant to food protection, active managerial controls, and food code adoption, will be offered. The Harrisburg Health Office will also participate in cooperative programs with other local health offices and stakeholders to insure consistent identification, management and enforcement of food safety regulations.